A MODEL FOR PREDICTION CTDS DUE TO REPETITIVE LOADING

Cumulative trauma disorders (CTDs) of the hand and wrist are an ever increasing problem for today's workforce. The long-term objective of this work is to decrease the proliferation of cumulative trauma disorders in the workplace. The specific aim of the proposed research is to demonstrate and evaluate an innovative method for dealing with CTDs in the workplace. The proposed effort is focused on the demonstration of a tendon adaptation model that is sensitive to repetition, force, posture and worker anthropometry. In addition, the model performance will be evaluated and sensitivity analysis performed on the model parameters. The proposed model has enormous potential in both preventing injuries and helping to design better products. With further validation the model can be used to establish a quantitative relationship between CTDs and work conditions. The ultimate result will be the ability to: identify high risk work conditions, quantify the problems providing a rational means of altering these conditions, and verify that the changes will indeed reduce the risks. Thus, rather than waiting until CTDs are reaching a debilitating state, this model will provide early detection and prevention.